Transformative personalized vascular disrupting cancer immunotherapy

DESCRIPTION (provided by applicant): While the majority of anticancer therapeutic efforts are designed to directly target tumor cells, there is a strong rationale for targeting the tumor vasculature (TV) instead. The development of vascular-specific tools for therapy has been hindered by (a) the paucity of targets, (b) lack of reagents with optimal affinity and specificity, and (c) their short-lived action due to rapid clearance and/or development of neutralizing antibodies. This proposal aims to solve current limitations in the field of cancer vascular therapy and generate a novel powerful and personalized approach of autologous adoptive vascular disrupting lymphocyte immunotherapy applicable to most tumor types. T cells will be engineered with lentiviral vectors to express chimeric immunoreceptors (CIRs), fusion molecules comprising an extracellular single chain variable fragment (scFv) antibody domain and intracytoplasmic CD3, CD28 and 4-1BB signaling domains for robust T-cell activation. Patient-derived lymphocytes will be genetically reprogrammed to recognize, get activated by and destroy specifically the tumor vasculature. This approach combines the sensitivity and power of cytotoxic T cells with the specificity of scFv, and will unleash on the tumor vasculature the power of acute transplant rejection. Besides specificity and safety, this approach offers durability and long-term memory. CIRs already developed against the tumor vascular surface proteins TEM1, TEM7R and PSMA will be used to validate the approach, while scFv against additional tumor vascular targets identified by the PI's lab and others will be developed. The successful completion of the project will bring to the clinic combinations of modular CIRs for personalized vascular immunotherapy for most common and most recalcitrant tumors. Safety will be maximized by requiring simultaneous recognition of two distinct tumor vascular antigens for T cell activation, by physically separating CD3 from CD28/4-1BB domains in two distinct CIRs, each recognizing a different tumor vascular target. The likelihood of both targets to be co-expressed in normal tissues is negligible, thereby maximizing the therapeutic window. Additional safety will be provided by the integration of a suicide gene in engineered T cells, which will also allow developing PET imaging to track T cell trafficking in real time in vivo. The parallel development of PET imaging capable of visualizing the tumor vasculature targets with the same scFv used in CIR will enable us to select the appropriate combinations of CIRs for personalized therapy and to monitor therapy. The impact of this approach could be transforming, given the power of tumor vascular disruption and its applicability across a wide range of targets shared by most common cancer types. The proposed approach can feasibly reach the clinic to deliver highly personalized cancer therapy of unparalleled power.

Public health relevance
Project Narrative We propose a novel approach to image and destroy tumor vasculature with a high degree of specificity by combining T-cell therapy and PET imaging. This approach will help identify patients who are the best candidates for the treatment; kill the tumor vasculature without targeting normal tissues, and allow treatment to be followed by PET imaging in the same sitting. The relevance to public health is that our approach will create new opportunities in the area of cancer detection and personalized therapy and improve the quality of life for ovarian cancer patients and prolong their life span. __SpecificAimsTextDelimiter__ Aim 1. Develop T cells transduced with HSV1-tk and CIRs directed against PSMA and TEM1 - Step 1, generate CIRs with signal 1 and/or 2 specific to TEM1 and PSMA, and HSV1-tk construct, and Step 2, in vitro analysis of surface expression and function of CIR: These will be completed with year 1. If D9, a scFv against human TEM1 does not afford sufficient avidity to engineered T cells, we will use the alternative scFv78 developed in collaboration with Dr Scholler, which has very high affinity (<1nM) for human and mouse TEM1. Additional scFvs are being developed against additional tumor vascular targets and can be incorporated to optimize our combinatorial design based on true prevalence and associations of tumor vascular targets. Aim 2. Build safety mechanisms in anti-vascular T cells - Step 1, Split signal 1 and 2 in separate CIRs, and Step 2, in vitro analysis of expression and HSV1-TK and response to GCV: These should be completed by year 2. We do not anticipate technical problems we cannot solve. Different bicistronic constructs will be tested to optimize expression of HSV-tk while preserving expression and function of CIR. As a back up we will test the HSV1-tk mutant, HSV1-sr39tk, which has enhanced affinity for various reporter probes 59. Dr Scholler will develop CIR with TEM7R as well as with scFv against TEM7, TEM8, ADAM12, ESM1 and CDCP1. This effort will be sustained from year 1 to year 5, with scFv optimization, testing in CIRs as described in aim 1, and testing in PET imaging. Aim 3. Test HSV1-tk transduced T cells to detect and destroy tumors with PSMA and TEM1+ vessels - Step 1, develop mouse model of tumor endothelium expressing human (h)TEM1 and PSMA in vivo: This should be completed by year 1. Step 2, in vivo tumor vascular targeting using ovarian cancer xenografts model from step 1 and CIR transduced T cells with or without HSV-tk. This should be completed by year 4. We expect the proposed models to allow completion of the proposed experiments. For better evaluation of safety we can use scFv78, which recognizes also mouse TEM1, thereby enabling to evaluate whether single-CIR or split-CIR T cells where TEM1 drives signal 1 differ in toxicity. In year 5 we will optimize adoptive T cell transfer and test combinations including the endothelin B receptor antagonist BQ-788 or other antiangiogenic agents. Aim 4. Use PET imaging to guide T cell therapy - Step 1, optimization of [18F]FHBG PET-CT imaging in the mouse: This should be complete by year 3. Step 2, integration with PET-CT imaging using [124I]-labeled MORAb-004: This should be completed by year 5. We expect available Abs to perform well in PET. As alternatives we are optimizing radiolabeling of scFv, which could be also used for tumor detection.